Post-Initiation control of transcription in inflammatory macrophages

Macrophage (MΦ)-driven inflammation is at the core of autoimmune diseases including rheumatoid arthritis
(RA), signifying imbalance between circuits that turn inflammatory genes on and off. The `on' state is conferred
by transcription factors such as NFκB that activate basal transcription machinery and chromatin at pro-
inflammatory enhancers and promoters. An equally robust `off' signal is conveyed by the glucocorticoid (GC)
receptor (GR) which, upon ligand binding, tethers to NFκB and represses its targets. Notably, these genes
form distinct classes: those for which RNA polymerase (Pol) II recruitment and transcription initiation are rate-
limiting, and those whose promoters are pre-loaded by initiated but paused Pol II and pause-enforcing factors,
NELF and DSIF. Pause-release requires the positive elongation factor, P-TEFb, a kinase that phosphorylates
Pol II, NELF and DSIF leading to NELF release and productive elongation. Importantly, assembly of the Pol II-
NELF-DSIF `paused complex' is tightly regulated by another kinase, CDK7. To date, the role of post-initiation
control of transcription in immunity and disease is unknown. Our preliminary data in MΦ reveal transcriptome-
wide Pol II pausing and unexpectedly dynamic behavior of NELF upon inflammatory stimulation. NELF deletion
dramatically shifted the balance of pro- and anti-inflammatory mediators and blunted inflammatory responses
over time. The pausing complex is also a critical target of GC - the cornerstone of anti-inflammatory therapies.
Although basal machinery and chromatin were once considered too general to be `druggable', pioneering work
in cancer research uncovered the benefits of targeting epigenetic regulators and, more recently, CDK7. In RA,
the transformation of the synovial lining into aggressively proliferating cartilage- and bone-invading tissue is
often viewed as malignant. Like tumor cells, synovial MΦ enter a state of transcriptional dependency with a few
super-enhancers dominating the inflammatory transcriptome. These data point to CDK7 inhibition as a novel
promising avenue to treat RA as a monotherapy or in combination with GC. Our objective is to dissect the
specific contribution of post-initiation control to inflammation - in MΦ and in mouse models of RA. Our central
hypothesis is that pausing plays an essential `permissive' role in MΦ-driven inflammation by constraining anti-
inflammatory gene expression. We further propose that genetic and pharmacologic manipulation of Pol II
pausing will yield important insights into the pathogenesis of inflammatory diseases such as RA, with potential
to be translated into advances in patient care. Our Specific Aims are to: 1. Dissect the role of the pause-
release checkpoint in inflammatory gene induction in MΦ; 2. Evaluate early elongation and higher-order
chromatin interactions in MΦ as targets for GR; 3. Assess the utility of manipulating elongation control in vivo
using inflammatory arthritis models. The successful completion of this project will: i) reveal the contribution of
Pol II pausing to inflammatory MΦ activation; ii) help refine the anti-inflammatory actions of GC; iii) uncover the
potential of new therapeutic strategies targeting the early elongation checkpoint in preclinical models of RA.

Public health relevance
Genes responsible for inflammation are tightly controlled by an enzyme RNA Polymerase II, that binds the beginning of each gene, pauses, and then transcribes genes to complete RNAs that ultimately give rise to proteins. Our recent studies show that in immune cells called macrophages, Polymerase `pause-release' is a critical step that determines how well most inflammatory genes are transcribed. Our proposal aims to understand the mechanisms of `pause-release' and the utility of chemicals that target pausing as future anti-inflammatory drugs for autoimmune diseases such as rheumatoid arthritis.